Admin Supplement - Center for Innovative TRIals in ChilDrEN and AdulTs (TRIDENT)

PROJECT SUMMARY/ABSTRACT A solid, supportive administrative team allows a network to run smoothly by providing support for meetings; developing and maintaining a platform for sharing documents; and ensuring communication is consistently provided to all members of the Network. The Duke/VUMC TIC provides administrative support to the Trial Innovation Network (TIN) to allow all of the TIN members including, TIC, RIC, CTSAs and NCATS to focus on the work that needs to occur for evaluating and testing innovative ideas and methods in clinical research.

Public health relevance
PROJECT NARRATIVE The Duke/VUMC TIC currently provides administrative support to the Trial Innovation Network (TIN). This work is critical to TIN functionality and ensures the TIN is able to thoroughly evaluate and test innovative ideas and methods in clinical research. The proposed supplement will allow the TIN to continue to provide infrastructure support to promote collaboration, communication, and teamwork.